AFDOSS Annual Educational Conferences 2022 - 2026

AFDOSS PROJECT SUMMARY/ABSTRACT
The objective of the AFDOSS Annual Educational Conference is to provide information on current and
emerging food, drug, and medical device topics impacting health and safety and helps build consensus
among the states on regulatory approaches to address them. The conference presentations give local,
state, and territorial regulators an opportunity to hear both a national and international perspective on
food, drug, and medical device safety.
AFDOSS anticipates 100 or more attendees from our region, representing ten (10) states and one (1) US
Territory, with participation from numerous county/local public health agencies. AFDOSS anticipates
being able to fund travel cost for a minimum of twenty-five (25) participants. We will target individuals
that otherwise might not attend due to economic constraints. Additional funds will be used to offset the
cost of meeting space rental, A/V equipment rental, and printing and supplies costs.

Public health relevance
AFDOSS PROJECT NARRATIVE AFDOSS Annual Educational Conferences provide information on current and emerging food, drug, and medical device topics impacting health and safety and helps build consensus among the states on regulatory approaches to address them. The conference presentations give local, state, and territorial regulators an opportunity to hear both a national and international perspective on food, drug, and medical device safety. Grant funding for travel costs enables participation of individuals that otherwise might not attend due to economic constraints.